VALE+TU SALUD: CORNER-BASED RANDOMIZED TRIAL TO TEST A LATINO DAY LABORER PROGRAM ADAPTED TO PREVENT COVID 19

ABSTRACT
Recent economic events in the United States have had a detrimental impact on the health of contingent construction workers. In Texas, contingent workers represent an important component of the construction workforce, particularly in entry level jobs often in the residential sector. Given the high level of task variability and frequent instability in this line of work, these adult male (>21YO) workers are routinely exposed to multiple interrelated personal and job-related stressors occurring in a working context that can be hazardous, temporary, and underpaid. Given these stressful conditions, contingent construction workers may be more prone to disease, including common respiratory infections, and may be less able to participate in healthy practices that prevent them. Critical healthy practices include (a) handwashing and staying away from others, (b) regular and preventive health care, (c) healthy eating habits, (d) use of health-related resources, and (e) maintaining supportive relationships to reduce the impact of stress on their health.
Based on a readily available and portable injury risk-reduction program that has been successfully tested among entry level construction workers, the “Your Health is Worth More” study will adapt its evidence-based participant recruitment, engagement, and intervention strategies to promote group problem-solving and the formulation of a plan of action to adopt practices that prevent common respiratory infections and protect workers health. This program will be tested in a cluster randomized trial to answer this question: Can a program for contingent workers in construction adapted to prevent common respiratory infections increase adherence to healthy practices that protect workers health? We intend to pursue the following aims to achieve this goal: AIM1: Determine the socioeconomic, interpersonal, and work-related factors that influence healthy practices adopted by contingent construction workers. AIM 2: Adapt, implement, and test “Your Health is Worth More” in a cluster randomized trial to assess the extent to which contingent construction workers report increased adherence with healthy practices that prevent common respiratory infections 1 month post intervention. Aim 3: Promote “Your Health is Worth More” just-in-time results and increase its capacity to rapidly disseminate findings among groups and organizations that support the health of contingent workers in construction and in similar job sectors.
We expect that in the short term, our program will address the need to promote better health among entry level construction workers by testing its effectiveness to encourage the adoption of healthy practices that prevent common respiratory infections. We also expect that the lessons learned in this prevention program will transfer to other work and life domains where contingent workers may adopt similar practices to reduce their risk of contracting disease and maintain good health.

Public health relevance
Public Health Relevance Section The purpose of this study is to test “Your Health is Worth More” in a cluster randomized trial in order to answer this question: Can a contingent construction worker program adapted to prevent common respiratory infections increase adherence to healthy practices that protect workers health? We will adapt, implement and evaluate a program that promotes healthy personal habits, regular and preventive health care, healthy eating, use of health-related resources, and maintain supportive relationships to reduce the impact of stress on health. If this program is successful, we will disseminate it among organizations that support the health of contingent construction workers and workers in similar job sectors.